AMINO AND KETO ANALOGUE INTERVENTION IN RENAL FAILURE

To see what mechanism in involved in suppressing glucocorticoid production (effected by reducing protein intake and supplementing ketoacids or amino acids) in patients with chronic renal failure.